Administrative Supplement for Equipment

Research Strategy
Summary of Parent Award: Enzymes with complex metallocofactors in their active sites catalyze myriad
transformations relevant to human health and disease. Understanding their reaction mechanisms requires
molecular-level characterization of their resting states and intermediate states, and metal-specific
spectroscopic techniques are especially useful in this endeavor. However, the high nuclearity of many
metallocofactors can limit the usefulness of such techniques; the signals arising from multiple metal sites
can be challenging to resolve, especially in mixtures of reaction intermediates. Moreover, it is often
impossible to map the rich spectroscopic information onto the geometric structure, and this severely limits
our understanding of the chemical bonding—and therefore the reactivity—of complex metallocofactors.
We propose to address these challenges by developing methods for modifying the isotopic and elemental
compositions of complex metallocofactors, in particular the nitrogenase catalytic cofactors. Nitrogenases
are responsible for supplying a significant portion of the fixed nitrogen on the planet, and they therefore
play an important role in maintaining a healthy and growing human population. Their catalytic cofactors
are among the most complex in Nature, and as a result their reaction mechanisms have been especially
difficult to characterize. To overcome these challenges and gain new insights into the mechanism of
biological nitrogen fixation, we will develop chemical methods for precisely altering the isotopic and
elemental composition of nitrogenase cofactors. Our approach is to discover mild protocols for removing
specific Fe sites in nitrogenase cofactors and subsequently replacing them with 57Fe. The site-selectivity
of the label will allow for the electronic structure (as elucidated spectroscopically) to be connected to the
geometric structure (as defined crystallographically), and will thereby provide unprecedented insights into
the chemical bonding and reactivity of nitrogenase cofactors. Studies of these cofactors in both their
resting states and intermediate states comprise the heart of the proposal. We will also extend the site-
selective 57Fe labeling protocol to incorporating different metals into specific sites of nitrogenase
cofactors. This will yield artificial metalloenzymes that will serve as mechanistic probes with potentially
unique properties and/or reactivity. Completion of this project will provide unprecedented mechanistic
insights into biological nitrogen fixation and will articulate concepts and protocols for rendering complex
metallocofactors as mechanistically tractable as mononuclear active sites.
Justification for proposed equipment: The proposed modern ultracentrifuge would replace our current
ultracentrifuge (a decades-old Beckman Coulter L70, heretofore referred to as the “Old Ultracentrifuge”),
which was listed in the Equipment section of our grant proposal submitted in 2021. We first describe the
scientific relevance of an ultracentrifuge with respect to this project, and then the reasons for replacing the
Old Ultracentrifuge with a modern ultracentrifuge.
Scientific necessity for a functioning ultracentrifuge. The project is absolutely dependent on large-scale
overproduction of nitrogenase proteins from Azotobacter vinelandii (Av), and this can only be
accomplished by conducting large-scale cell growths and protein purifications. The extraction of
nitrogenase proteins from Av cells (50-150 g) requires cell lysis and clarification of the cell lysate in an
ultracentrifuge; without this step, particles in the lysate would clog the chromatography resins, rendering
protein purification nearly impossible. Thus, an ultracentrifuge is critical for cell lysis. Indeed, when the
Old Ultracentrifuge is broken, the project grinds to a halt because every experiment requires access to
nitrogenase proteins (e.g., the Mo nitrogenase) and/or nitrogenase-protein-derived cofactors (e.g., FeMo-
co, the catalytic cofactor of the Mo nitrogenase, which is extracted from the Mo nitrogenase). The specific
aims that would be affected without an ultracentrifuge are:
1. Aim 1. This Aim cannot be undertaken because it relies on the large-scale isolation of nitrogenase
cofactors.
2. Aim 2. This Aim cannot be undertaken because it relies on the large-scale isolation of nitrogenase
cofactors as well as the apo-proteins in which they are reinserted.
3. Aim 3. This Aim cannot be undertaken for the same reasons as articulated for Aim 2.
Simply put: an ultracentrifuge is one of a few critical pieces of equipment, without which the project
cannot be pursued.
Rational for purchasing a modern ultracentrifuge. My lab inherited the Old Ultracentrifuge from Prof.
Stephen Lippard, who purchased this equipment many years ago. Because of its age and because we use
it frequently, it breaks several times per year. This has not significantly slowed down our research progress
because it is typically repaired within a few days by a talented technician from Beckman Coulter.
However, Beckman Coulter recently informed us that they have stopped making replacement parts and
we will therefore no longer be able to source them. As such, Beckman Coulter is not guaranteeing the
repairability of the Old Centrifuge, which means that it is essentially obsolete; soon (probably within a
year), the Old Centrifuge will break and will remain permanently broken. This will be catastrophic for our
research project for the reasons described above.
Replacing the Old Centrifuge with a modern centrifuge would solve this problem since a modern
centrifuge would be serviceable now and for the remainder of the project. Additionally, it would likely
break far less frequently, and thus would result in less down-time in our research efforts.
Note that we are proposing to purchase a modern ultracentrifuge (Beckman Optima XE) that has
essentially the same features as the Old Ultracentrifuge. The Optima XE is not only their best-selling
model, it’s also their most economical ultracentrifuge, and as such, our proposal to purchase this piece of
equipment is financially conservative.
Future costs. There will be no additional costs associated with the new ultracentrifuge as any repairs will
be covered under a service contract.

Public health relevance
Project Narrative Enzymes that bind iron–sulfur clusters are found in all kingdoms of life and perform reactions that play central roles in human health, including the generation of ammonia fertilizer from air. We propose to study the chemical bond-making and -breaking steps of these reactions by developing methods for modifying the isotopic and elemental compositions of their catalytic clusters.